Career Enhancement Core

The Center for the Assessment of Tobacco Regulations Career Enhancement Core (CEC) will serve as the hub within CAsToR to promote and support the career development of new and early-stage investigators. The overall goal of the CEC is to support the advancement of junior researchers in becoming independent Tobacco Regulatory Science (TRS) investigators who use or collaborate with others who use simulation and computational modeling approaches in TRS. The CEC will provide junior investigators with mentored research experiences, educational activities, mentorship, professional networking opportunities, and scientific communications training in TRS, with an emphasis on simulation and computational modeling research.